RANDOMIZED DOUBLE BLIND STUDY TO EVALUATE BIOLOGIC ACTIVITY OF BG9273

The study will evaluate the safety, pharmacokinetics, and biological activity of various doses on intravenous LFA-3 IfG1 in patients with moderate to severe psoriasis vulgaris.